Hooten 1 S06 GM092233-01 Project 1 (NARCH)

This funding will develop opportunities for conducting research and research training to meet the needs of American Indian/Alaska Native (AI/AN) communities.